Dissecting the role of the Fanconi anemia pathway in chromothripsis

PROJECT SUMMARY/ABSTRACT
Cancer-associated chromosomal abnormalities frequently arise through punctuated episodes of genomic
instability. This is exemplified by chromothripsis, the shattering and re-stitching of individual chromosomes, which
generates a distinct rearrangement signature in ~30% of pan-cancer genomes. Chromothripsis is driven by
mitotic errors and the formation of aberrant nuclear bodies termed micronuclei that entrap mis-segregated
chromosomes outside of the nucleus. Due to defects in nuclear envelope assembly, micronuclei undergo
frequent and irreversible rupture that inactivates normal nuclear processes, including DNA replication, DNA
repair, and transcription. During mitotic entry, chromosomes in micronuclei undergo extensive breakage into tens
to hundreds of fragments through incompletely defined mechanism(s). Our laboratory recently identified that
fragmented chromosomes remain bound throughout mitosis by protein-mediated tethers, which facilitates the
re-incorporation of the fragments into the nucleus and its subsequent reassembly. This cascade gives rise to the
highly complex yet localized rearrangements that are often observed in cancer genomes. In addition to the
deletion of tumor suppressor genes and/or formation of oncogenic fusion genes, chromothripsis can also result
in the circularization and amplification of genes on extrachromosomal DNAs (ecDNAs). While several key
mechanistic steps have been well characterized, the source(s) of mitotic chromosome fragmentation remain
unclear. To identify genetic drivers of chromothripsis, I recently conducted pooled CRISPR-Cas9 screens using
a chromosome-specific micronucleus system. I unexpectedly identified that a genome maintenance mechanism
known as the Fanconi anemia (FA) pathway functions as a critical driver of chromothripsis and complex genomic
rearrangements. My preliminary data suggest that the FA pathway promotes mitotic chromosome shattering
through the recruitment of structure-specific DNA endonucleases to under-replicated DNA intermediates from
micronuclei, which is then followed by mitotic DNA synthesis, a process that may be analogous to the processing
of late-replicating fragile sites in the genome. Here I propose to further define the role of the FA pathway and
mitotic DNA synthesis in chromothripsis. First, I will comprehensively identify regions of the micronucleated
chromosome undergoing active processing during mitosis by the FA pathway. I will also determine whether
mitotic DNA synthesis is required for priming fragments for reassembly in the next cell cycle. Second, I will
leverage pre-clinical cell models to investigate whether inhibition of the FA pathway represents a feasible
therapeutic strategy to suppress chromothripsis-induced emergence of drug-resistant cancer cells harboring
ecDNAs. These studies will shed light on how a genome-protective DNA repair mechanism can be co-opted as
a pathological driver of cancer genome instability. In addition to this research plan and with support from my
sponsor, co-sponsor, and dissertation committee, I have also established a well-defined training and career
development plan that will further bolster my abilities as an independent researcher focused on cancer biology.

Public health relevance
PROJECT NARRATIVE Cancer genomes commonly harbor complex rearrangements that arise through chromothripsis, the catastrophic fragmentation and reassembly of individual chromosomes. Chromothripsis originates from mis-segregated chromosomes in micronuclei, yet our understanding of the causes and consequences of chromothripsis is limited. This proposal seeks to define the mechanisms by which the Fanconi anemia pathway promotes chromosome fragmentation and the generation of highly rearranged chromosomes.